Neurophysiology of impaired gait in mouse models of Parkinson’s disease

Project Summary
Walking is one of the most essential forms of mammalian behavior, but there is still only an incomplete
understanding of the neural mechanisms that control gait performance at the level of individual limbs and steps.
Several movement disorders including Parkinson’s disease (PD) are associated with impaired gait, and current
therapies are often only partially effective at alleviating these motor symptoms. The basal ganglia are a set of
subcortical nuclei that are strongly implicated in Parkinsonian motor symptoms. However, most efforts to link
motor deficits with altered basal ganglia activity in PD animal models have focused on relatively low spatial
resolution measures of motion such as movement initiation, termination, and whole-body speed. This leaves a
large unmet need to study the neurophysiological basis of impaired gait in PD animal models with single-limb
and step resolution. This project will examine how the dorsolateral striatum and substantia nigra pars reticulata,
a major input and output nucleus of the basal ganglia, encode gait information in two complementary mouse PD
models. Experiments will use high speed video, automated behavioral tracking, single-unit electrophysiology
from genetically identified cell types, and optogenetic manipulations to mimic or rescue motor impairments in the
unilateral 6-hydroxydopamine (6OHDA) and alpha-synuclein preformed fibril models of PD. This proposal is
motivated by novel electrophysiological data suggesting that a sizable fraction of neurons in the striatum and
substantia nigra are normally coupled to the cycle of limb movements during walking. Furthermore, lesioning
dopamine with unilateral 6OHDA injections disrupts the normal balance of gait phase coding between direct and
indirect pathway neurons in the striatum. Aim 1 will build on these preliminary results by identifying the neural
signatures of impaired gait and other, more commonly studied measures of motion (start/stop and whole-body
speed), in 6OHDA lesioned mice on and off dopamine replacement medication. Aim 2 will track the progression
of gait impairments and movement-related neural activity changes in the alpha-synuclein preformed fibril model.
Finally, Aim 3 will determine whether manipulating certain basal ganglia cell types can impair single-limb gait
performance in healthy animals, or rescue gait in PD models. Together, this project will significantly advance our
understanding of the basal ganglia’s role in encoding and controlling gait in PD animal models.

Public health relevance
Project Narrative Impairments in limb movements during walking, or gait, are a debilitating motor symptom of Parkinson’s disease for which no fully effective treatment exists. The neural circuit mechanisms that cause these gait disturbances have not been well studied at the resolution of individual limb movements. Therefore, the goal of this project is to understand how gait-related brain activity is altered in animal models of Parkinson's disease.